SUPPORT OF COLLABORATIVE STUDIES OF EXPOSURE TO ENVIRONMENTAL CONTAMINANTS IN RELATION TO CHILD HEALTH IN THE GENERATION R STUDY

The contract supports a scientific collaboration between investigators at NIEHS and those conducting the Generation R Study. The Generation R Study has previously collected multiple urine specimens from pregnant women and has followed the children with in-person assessments at age 6 years. In this collaborative project we will select urine specimens for analysis, get the specimens analyzed, and then relate the results to child development, to identify adverse effects, if any, of background-level exposure to environmental contaminants.